Protective functions of influenza-specific lung-resident memory B cells

PROJECT SUMMARY
We recently identified a novel population of flu-specific, lung-resident memory B cells (BRM cells) that are
phenotypically different than systemic memory B cells, reside in unique sites in the lung and respond more rapidly
to challenge infection than their systemic counterparts. Interestingly, lung BRM cells provide a significant degree
of protection to challenge infection, even when they do not cross-react with the HA and NA proteins of the
challenge virus, suggesting that BRM cells have additional effector functions beyond antibody (Ab) production.
In fact, B cells make inflammatory cytokines like IFN, lymphotoxin, OX40L and IL-6, as well as anti-inflammatory
cytokines like IL-10, IL-27 and IL-35. Moreover they are potent APCs, particularly for their cognate antigens.
Thus, BRM cells have a variety of mechanisms, in addition to Ab, to modulate inflammation and promote anti-
viral immunity. The experiments in this proposal will investigate the mechanisms used by flu-specific BRM cells
to clear virus and protect the lung and will determine how pulmonary vaccination can elicit and maintain BRM
cells in the lung.

Public health relevance
PROJECT NARRATIVE. The experiments in this proposal will examine the functions of memory B cells that live in the lung and respond to influenza infection and compare them with memory B cells that live at systemic sites. We will also determine how various vaccination strategies enhance or impair the formation of memory B cells in the lung, experiments that are critically important for understanding how and when vaccines should be administered in the respiratory tract.